Postpartum low-dose aspirin to augment vascular recovery following a hypertensive disorder of pregnancy

PROJECT ABSTRACT
Cardiovascular disease (CVD) is the leading cause of death in women worldwide and despite declines in all
other age groups, mortality rates attributed to CVD are increasing in women of childbearing age. Preeclampsia
is a well-established risk factor for CVD across diverse patient populations, however, there are currently no
evidence-based interventions targeting this at-risk patient population. While blood pressure control is the
cornerstone of postpartum management, emerging evidence suggests that management of hypertension alone
does not fully mitigate CVD risk after preeclampsia. The overall goal of this line of research is to begin to
develop and test novel pharmacologic interventions for postpartum management following preeclampsia,
representing a paradigm shift focused on endothelial recovery postpartum in addition to blood pressure control.
In this application, the objective is to conduct a single-site pilot trial to assess the feasibility and effect of low-
dose aspirin to augment vascular recovery in the immediate postpartum period after preeclampsia through two
specific aims: to pilot test the feasibility of conducting a randomized controlled trial of postpartum low-dose
aspirin vs. placebo, and 2) to assess the effect of postpartum aspirin on endothelial function and blood
pressure. Our central hypothesis is that postpartum administration of low-dose aspirin following preeclampsia
will be feasible, improve endothelial function, and lower BP at 6 months postpartum. The research proposed in
this application is innovative in its novel adaptation of an evidence-based strategy to improve vascular function
and postpartum blood pressure in an understudied population with significant morbidity during a critical time
period. This proposal is significant as it will provide an opportunity to assess the feasibility and explore the
effect of low-dose aspirin on vascular function in addition to blood pressure. Effective interventions to improve
postpartum hypertension care and reduce long-term cardiovascular risk have broad implications for improving
maternal morbidity and reducing disparities in care. Our findings will provide a valuable framework to inform a
subsequent large-scale randomized trial of low-dose aspirin in the postpartum period following preeclampsia.
Successful completion of this line of research would represent a transformation in postpartum management of
women with hypertensive disorders of pregnancy and have a direct impact to improve hypertension and
cardiovascular-related maternal morbidity and mortality.

Public health relevance
PROJECT NARRATIVE The proposed line of research is relevant to public health in that it represents a novel approach to postpartum management of preeclampsia. Once such an approach has been developed and tested, it would have broad implications for reducing maternal morbidity and improving disparities in postpartum hypertension care. Thus, the proposed research is relevant to the part of the NIH's mission that pertains to reducing illness and disability through innovative research strategies.